Development and Pilot Evaluation of an Online Intervention to Prevent Dating Violence and Problem Drinking in Sexual Minority Youth

Project Summary
Dating violence (DV) is strongly associated with alcohol use (AU), and both DV and AU occur at alarmingly
high rates among sexual minority youth in part because of increased minority stress4,7,18 and decreased sense
of community.19,20 Prevention programming that targets these two modifiable risk and protective factors (i.e.,
minority stress and sense of community) in conjunction with other evidence-based DV and AU components
(e.g., bystander intervention, refusal skills, personalized normative feedback, protective behavior strategies)
could ultimately reduce rates of DV and AU and related health risk behaviors (e.g., sexual risk-taking) among
LGBTQ+ youth. The proposed project seeks to develop a new synchronous online DV and AU prevention
initiative for LGBTQ+ youth (15 to 18 years old), preliminarily entitled Radicalizing Respect and Relationships
(R3). The theoretically grounded R3 Prevention Initiative (R3-PI) follows best practices for effective health
behavior prevention programming,13,14 and is expected to include eight 45-minute modules intended for
delivery as an online, small group program. Following a Stage 1A and 1B model, during the Development
Phase we will finalize and refine the R3-PI materials; these materials will be developed based on the project
team’s expertise and knowledge of the extant literature, key informant feedback (i.e., LGBTQ+ youth advisory
board, experts in the field), as well as feedback from youth during an open pilot trial. During the Pilot Study
Phase, 200 LGBTQ+ youth who are dating will be recruited using social media and other online
advertisements and randomly assigned to a wait-list control (n = 100) or R3-PI (n = 100) conditions. Pre-,
immediate, and 3-month posttests will assess the acceptability of the study procedures (e.g., compliance with
survey procedures) and generate initial data on the efficacy of the R3-PI. We will also assess acceptability and
feasibility of the program and research procedures via post-session surveys, program observations,
evaluations of adherence and drop-out rates, and online exit interviews with a subsample of youth (n = 15 or
until saturation is achieved). Ultimately, the proposed project has the potential for high public health impact
because we will develop the first-ever DV and AU prevention initiative specifically tailored for LGBTQ+ youth.
Further, given the online delivery format of this intervention, it has the potential to reach LGBTQ+ youth across
the U.S., including youth in rural and remote areas where rates of minority stress are highest and LGBTQ+
sense of community is lowest and where fewer resources to address risk and promote resilience are
available.16

Public health relevance
Project Narrative Dating violence (DV) and alcohol use (AU) occur at alarmingly high rates among LGBTQ+ youth, and minority stress is a unique and critically important risk factor for DV and AU in LGBTQ+ youth, whereas the sense of community with other LGBTQ+ youth can serve as a protective factor. The overarching goal of the proposed project is to develop an innovative, online synchronous DV and AU prevention curriculum created specifically for LGBTQ+ youth (ages 15 to 18); conduct a pilot randomized controlled trial to assess its feasibility and acceptability of the intervention and study procedures; and identify preliminary outcomes of the intervention. The project focuses on two interrelated and significant public health issues (i.e., DV and AU), proposes an innovative approach to prevent them, and is highly consistent with the Healthy People 2020 goals of reducing violence and substance use and improving the health, safety, and well-being of LGBTQ+ individuals.